HIV-1 Fusion on Native Membranes Captured by Cryo-Electron Tomography

HIV-1 Fusion on Native Membranes Captured by Cryo-Electron Tomography
Summary
Human immunodeficiency virus 1 (HIV-1) infection is initiated by binding to host cells through interactions of the viral
envelope glycoprotein (Env) with the cellular receptor CD4 and co-receptors CCR5 or CXCR4. While structures of Env in
complex with soluble domains of these receptors have been determined in vitro, the understanding of how these proteins
interact on membranes to mediate fusion remains incomplete. Specifically, it is poorly understood how Env, CD4,
CCR5/CXCR4 and membranes interact in a higher-order manner at membrane-membrane interfaces, and how the
conformational changes of Env, triggered by the engagement of receptors, lead to membrane fusion. These molecular events
need to be investigated in their native environment on membranes, where virus fusion occurs. Using a virus-like particle
(VLP) system and cryo-electron tomography (cryoET), we have recently reconstituted prefusion membrane-membrane
interfaces and revealed unprecedented intermediates of HIV-1 Env bound to one, two, and three CD4 molecules. At these
interfaces, Env–CD4 complexes organized into clusters and rings, bringing the opposing membranes closer. Although
adopted to an open conformation, the Env trimer bound to three CD4 molecules did not engage the membrane-embedded
co-receptor, likely due to steric constraints imposed by membrane-associated CD4 molecules. Consequently, key structures
such as HIV-1 Env bound to co-receptors and Env intermediates during refolding that drive membrane fusion are still
missing. Here, we propose to extend our research into the dynamics of HIV-1 fusion using cryoET and integrate molecular
dynamics (MD) simulations to understand how these components orchestrate the fusion process, to determine the structural
intermediates during HIV-1 Env refolding that drive fusion, and to investigate the mechanisms by which fusion inhibitors
block HIV-1 infection. Specifically, we will 1) determine if HIV-1 Env-CD4 receptor clustering is necessary or advantageous
for HIV-1 Env fusion, 2) determine how Env binds to coreceptor followed by the refolding of gp41 that drives membrane
fusion, and 3) investigate the timeline of action for various HIV-1 fusion inhibitors and their effects on the conformational
transitions of Env during fusion.

Public health relevance
Narrative This project investigates the molecular events during HIV-1 fusion in their native membrane environments. Utilizing cryo- electron tomography (cryoET) to capture in situ structural information, complemented by molecular dynamics (MD) simulations, the study aims to provide detailed insights that can inform the development of innovative therapeutic strategies against HIV-1.